University of Pennsylvania Patient-derived Xenograft Development and Trials Center

Project Summary/Abstract:
The overall goal of the University of Pennsylvania PDX Development and Therapeutics Center (UP-PDTC) is
to (i) exploit the translational potential of PDX models for evaluating the response of various treatments in
models with specific molecular characteristics and to (ii) work with PDXNet to enhance and extend use of PDX
models to the research community with the goal to guide development of human Phase 1/2 clinical trials for
human malignancies. As PDX models more faithfully reproduce human cancer than cell lines, they can
contribute to the ultimate clinical implementation of cancer precision medicine. The UP-PDTC is uniquely
poised to contribute to such research due to the long history of PDX research at UPENN. The UP-PDTC will
comprise 4 Cores and 2 projects. The four Cores are: Administrative, PDX, Pilot Projects and Trans-Network,
and a Bioinformatics Core. The Administrative Core will coordinate all UP-PDTC activities. The PDX Core
builds on 15 years of experience within the Stem Cell and Xenograft Core facility of UPENN. The PDX Core
currently provides over 900 mice per month to investigators at UPENN using PDX modeling for malignant and
non-malignant disease. The animal facility of the PDX Core is a dedicated 6 room suite controlled by highly
skilled PDX Core personnel with comprehensive infection control measures. Using these measures, the PDX
Core has not had a significant infection in the colony in seven years. The Pilot Projects Core will take
advantage of a growing group of collaborators to build tissue banks for hepatocellular carcinoma (HCC), clear
cell renal cell carcinoma (ccRCC), breast cancer, glioblastoma, and myeloma. A major goal of the UP-PDTC is
to develop and characterize new models across common and rare cancer types that can be linked with the
originating patient clinical response profile and shared with PDXNet. The Bioinformatics Core takes advantage
of the extensive Bioinformatics infrastructure at UPENN and will work with the Projects to more rigorously
describe PDX modeling for acute myeloid leukemia (AML) and ovarian cancer. There are two projects. Project
One is directed by Dr. Martin Carroll and will focus on acute myeloid leukemia. Project 1 takes advantage of
one of the largest tissue banks of viable, fully annotated AML samples in the world. This tissue bank currently
has over 3300 collections from over 1700 patients collected over 20 years including over 40 PDX primograft
models currently available of over 100 that have been described. Dr. Carroll, working with members of the
PDX Core, has a long history of developing and using the AML PDX model to define AML biology and
responses to therapy. Project 2 is directed by Dr. Fiona Simpkins and takes advantage of the Ovarian Cancer
Research Center Tumor BioTrust Collection. This collection is fifteen years old, also fully annotated and
includes 140 well characterized PDX models. Drs. Carroll and Simpkins, have extensive experience in
xenotransplantation models and in the use of xenotransplantation models to both understand disease biology
and develop new therapeutic approaches for implementation in clinical trials. In their projects, they propose
two discrete xenotransplantation Phase 2 studies. Dr. Carroll will test the effects of a combined therapy with
Menin inhibition and KAT6A inhibition on AML differentiation and disease burden. Dr. Simpkins will study
TP53 wild type clear cell ovarian carcinoma (CCOC) and low-grade serous ovarian carcinoma (LGSOC) and
their response in PDX models to a “p53 stabilizer combination” (MDM2 and XPO1 inhibition). Both Dr. Carroll
and Dr. Simpkins have significant experience moving pre-clinical work into human early-stage clinical trials and
we anticipate that these xenotransplant phase 2 (XP2) studies will lead to molecular defined Phase 1/2 human
studies. Overall, the unique resources of the UP-PDTC should enhance the use of PDX models for robust and
reproducible studies that will lead to precision targeted therapeutics in humans.

Public health relevance
University of Pennsylvania PDX Development and Trial Centers Project Narrative – Human malignancies, particularly AML and ovarian, continue to have a high mortality. We will optimize human patient derived xenotransplantation models for AML, ovarian cancer and other malignancies and use these models to test new therapies for these diseases.